Structural Dynamics of NFkappaB Signaling Complexes

Stress-response transcription factors must be tightly regulated so that they remain completely inactive in the resting state of the cell, are robustly activated in response to the appropriate signals, and are then rapidly and completely inactivated to avoid inappropriate gene expression when the stress condition is mitigated. The stress- response transcription factor nuclear factor κB (NFκB) regulates cell growth, immune responses, inflammatory viral responses, and apoptotic cell death and is often misregulated in cancer, arthritis, asthma, diabetes, AIDS, and viral infections. Members of the NFκB family of transcription factors are held in the cytoplasm in an inactive state by their bound inhibitors (IκBs) until the cell receives an external signal. NFκB is activated by phosphorylation and ubiquitination of the IκBα, which is then targeted for proteasomal degradation, releasing the NFκB to translocate into the nucleus. In a classical negative feedback mechanism, NFκB upregulates transcription of IκBα in addition to signal-specific stress-response genes: newly-synthesized IκBα kinetically enhances NFκB dissociation from the DNA in a process we have termed molecular stripping. A transient ternary complex intermediate is formed during the stripping process; we characterized this ternary complex by NMR and cryo-EM at equilibrium, and demonstrated by stopped-flow methods at lower concentrations that the dissociation of NFκB from its cognate DNA is accelerated by IκBα. In an exciting new observation, it has recently been shown that the stability of the resting NFκB-IκBα complex in the cytoplasm is enhanced by interaction with a specific long non-coding RNA (lncRNA), which appears to form a stable ternary complex analogous to the transient NFκB-IκBα-DNA complex formed in the nucleus during molecular stripping. Specific Aim 1 of this proposal is concerned with the structural characterization of this NFκB-IκBα-RNA complex using a variety of biophysical techniques, including NMR, cryo-electron microscopy, in collaboration with Dr. Gabriel Lander, and small-angle X-ray scattering, in collaboration with Dr. John Tainer. Specific Aim 2 will probe the structural and dynamic differences between the binary and ternary complexes of NFκB, IκBα and DNA, and the ternary NFκB-IκBα-RNA complex using specifically methyl-labeled proteins. Labeling methods and NMR experiments pioneered by the Kay lab at the University of Toronto enable dynamic information to be obtained even on systems as large as the NFκB-IκBα complexes, and we have demonstrated in previous work that this system is amenable to these approaches. Fulfilment of these specific aims will enable us to describe the structures and dynamics of these large dynamic complexes in unprecedented detail, and we anticipate that the experimental design utilized in this project will provide an important precedent for the study of the many other dynamic macromolecular complexes that have remained difficult to characterize.

Public health relevance
The nuclear factor κB (NFκB) signaling system regulates cell growth, immune responses, inflammatory viral responses, and apoptotic death and is often misregulated in cancer, arthritis, asthma, diabetes, AIDS, and viral infections. We propose studies aimed towards a detailed understanding of the structural and dynamic mechanisms by which NFκB proteins interact with their partners, using a biophysical approach combining a range of different techniques. Such an understanding is an important prerequisite for the design of drugs directed towards these targets.